Using natural products to decipher essential host-parasite interactions in visceral leishmaniasis.

1 PROJECT SUMMARY:
2 Visceral leishmaniasis is a vector-borne neglected tropical disease (NTD) caused by Leishmania
3 donovani and Leishmania infantum. During infection, Leishmania parasites alter host responses in
4 innate immune cells, such as macrophages (MΦ’s), to ensure parasite survival and replication in the
5 parasitophorous vacuole (PV). Understanding the cellular pathways that are subverted during
6 Leishmania infections provides a unique opportunity to elucidate the host-parasite interactions
7 necessary for successful infection. The long-term goal of this project is to identify natural products
8 that modify host-parasite interactions required for parasite replication while engaging a diverse group
9 of undergraduate research students. The overall objective is to identify the mechanism of action of
10 sulforaphane (SFN) to determine its antileishmanial properties. We hypothesize that SFN modifies
11 host and parasite pathways to inhibit intracellular amastigote replication. Our hypothesis is based on
12 our recently published work that establishes SFN is an effective anti-parasitic compound that inhibits
13 both promastigote and amastigote replication. The rationale underlying this proposal is that a
14 systematic study of the mechanisms controlled by SFN will provide a better appreciation of how
15 Leishmania successfully replicate inside MΦ’s. The overall objective will be accomplished by pursing
16 the following two specific aims: 1) identify the extent to which SFN activates nuclear factor erythroid
17 2-related factor 2 (NRF2)-dependent and -independent pathways to inhibit Leishmania replication,
18 and 2) identify the extent to which SFN modifies host autophagic flux to decrease parasite levels.
19 Under the first aim, our working hypothesis is that SFN sustains host NRF2-dependent gene
20 expression during the infection to reduce amastigote replication. The NRF2 pathway will be activated
21 post-infection through SFN and specific NRF2 activators in both wild-type and NRF2 knockout MΦ’s.
22 Amastigote levels will be quantified through fluorescence microscopy. Host and parasite
23 transcriptomics will be quantified through bioinformatics analysis. The second aim, based on
24 preliminary data, indicates that SFN inhibits autophagy to increase the number of autophagosomes
25 thereby reducing the number of intracellular amastigotes. Autophagic flux will be quantified through
26 fluorescence microscopy and protein analysis of autophagy related proteins in WT and LAMP2 KO
27 MΦ’s. Amastigote levels will be quantified, and essential host proteins associated with amastigote
28 maturation in the PV will be determined by confocal microscopy. This proposal is significant because
29 the resulting mechanistic understanding of host-parasite interactions will clarify the role of NRF2 and
30 autophagy within the innate immune cells during parasitic infections within the PV.

Public health relevance
PROJECT NARRATIVE: Visceral leishmaniasis (VL) is a parasitic disease caused by a sand fly bite that leads to death in most untreated cases. This project aims to ascertain the immunomodulatory effects of a natural product, sulforaphane, on human macrophages during infection in order to develop a better understanding of essential host-parasite interactions necessary for successful infection.